Supplement for Supporting Patients and Family Care Partners to Manage Chronic Kidney Disease Together

PROJECT SUMMARY
Candidate: Nicole DePasquale, PhD, MSPH, is an Assistant Professor at the Duke University School of
Medicine and is fully committed to becoming an independently-funded investigator at the intersection of
dyadic science and disease management. Her long-term career goal is to develop family-centered interventions
to optimize individual and dyadic health among older adults with chronic disease and their family care
partners. Dr. DePasquale’s interdisciplinary background makes her an ideal candidate to merge these two
largely separate areas of inquiry. Her previous scientific training spans multiple fields of study, and her
research experiences have been both quantitative and qualitative in nature.
Career development and training plan: Dr. DePasquale’s career development and training plan feature a
multidisciplinary mentoring team comprising a general internist/clinical epidemiologist, geriatrician, health
services researcher, social/health psychologist, biostatistician, and board-certified nephrologist. This team will
support her pursuit of 5 training areas chosen to provide targeted theoretical, methodological, and practical
expertise needed to complete the K01 research and facilitate her transition to complete independence: 1) the
fundamental aspects of caring for aging patients with kidney disease, 2) dyadic disease management, 3) applied
research design and advanced quantitative and qualitative analytical techniques, 4) the development and
testing of family-centered interventions, and 5) professional development (best research practices, research
collaborations, leadership, and grant writing). Additional resources to foster her career development include
Duke’s Claude D. Pepper Center; Edward R. Roybal Center; Offices for Faculty Development, Scientific
Integrity, Research Mentoring, and Research Development; and Clinical Research Training Program.
Research plan: The proposed research will use different methodological approaches to understand ways in
which older patients and their family care partners manage the full course of chronic kidney disease (CKD)
together, and how dyadic management affects individual and dyadic health. This research has 3 aims: 1)
quantify associations of care partner contributions to disease self-care with patient CKD self-management self-
efficacy and depression over time (secondary data analysis); 2) investigate the interrelations of dyadic disease
appraisal, disease management, and health along the continuum of CKD progression (primary data collection
through patient and care partner interviews and surveys); and 3) adapt and pilot test the feasibility of SHARE
for CKD, a care planning program to support care dyads’ management of CKD, with CKD care dyads. The goal
of this work is to move beyond individual experiences and outcomes related to CKD self-management by
focusing on shared management within the care dyad, which will assist research, clinical care, and health
policies in better supporting patients and care partners alike. Findings will provide Dr. DePasquale with
preliminary data to refine SHARE for CKD and test its effectiveness in a R01-funded trial.

Public health relevance
PROJECT NARRATIVE Chronic kidney disease is a progressive, life-altering condition characterized by substantial burden, increased health care costs, and disproportionate prevalence in older adults. Because older adults often require support from family care partners to self-manage chronic disease, it is critical to acquire an understanding of how to best support both patients and their care partners as they experience and navigate the full course of chronic kidney disease. The parent project leverages existing resources, uses multi-method approaches, and proposes data collection to understand the different ways in which older patient-family care partner dyads work together to manage chronic kidney disease over time and the impact of dyadic disease management on health and well- being at the individual-level and dyad-level; this information will then be used to adapt and test the feasibility of a novel, dyad-focused intervention designed to jointly benefit patients and family care partners.